Mechanisms of Integrative and Conjugative Elements in Oral Bacteria

Project Summary
Streptococcus mutans resides in the oral cavity where it is known to initiate the development of dental caries
(tooth decay). For this pathogen to thrive in the dynamic and variable environment of the mouth it must be
adaptable both to short- and long-term ecological pressures. The horizontal acquisition of new DNA, which
may encode for new beneficial traits, is a critical aspect of S. mutans adaptability. In addition, regulation of the
processes involved in the acquisition of DNA are intertwined with the basic physiology and stress responses of
S. mutans. In recent work supported by R03 DE029882, we investigated an integrative and conjugative
element (ICE) carried by S. mutans. ICEs are mobile elements that are integrated on the genome and possess
the ability to transfer to nearby bacteria via conjugation. Importantly, these elements can transfer new traits to
bacteria, and this can spread genes related to antibiotic resistance, metabolism, and virulence. We have
discovered several notable features of this ICE, including a potentially sophisticated regulatory system and that
activation has critical effects on S. mutans physiology. Despite ICEs being frequently present on bacterial
genomes, studies of their molecular mechanisms are lacking and very little is known about ICEs in oral
bacteria. It is therefore a high priority to understand how these gene transfer systems are activated/regulated,
how they impact host physiology, and how they could spread traits among oral bacteria. To address this, we
have developed three Specific Aims: Aim 1: Dissect the regulatory mechanisms that control the switch from the
integrated to excised state of TnSmu1; Aim 2: Examine TnSmu1-mediated phenotypic heterogeneity including
mechanisms of a growth arrest outcome; and Aim 3: Analysis of ICE transfer between bacteria in biofilm
communities. Taken together, the information derived from these studies will provide a wealth of new
knowledge for an unexplored mechanism of gene transfer in the oral microbiome. It is anticipated that the
results will provide novel insights into the functioning of the ICE carried by S. mutans, and that these insights
will have a broader impact on our knowledge of ICEs carried by other oral bacteria. Elucidation of how these
gene transfer systems work is critical for a deeper understanding of pathogen adaptability and then harnessing
this knowledge to develop more comprehensive strategies to eliminate disease.

Public health relevance
Project Narrative Gene transfer drives the adaptive evolution of bacterial pathogens and contributes to their pathogenesis. We recently discovered a gene transfer mechanism in Streptococcus mutans that shares similarity with a common type of mobile element that relies on conjugation to transfer DNA from host to a recipient. In this project we will investigate the signals that govern this transfer, mechanisms that may ultimately harm the host, and track transfer of the element among cells growing as a biofilm.